"SMART" nanoparticle delivery of veratridine overcomes clinical challenges in metastatic colorectal cancer.

Project Summary
Colorectal cancer (CRC) has a high mortality rate due to metastasis and drug resistance. CRC cells develop
metastatic characteristics by hijacking different signaling pathways to fuel tumor heterogeneity and facilitate
cancer migration and invasion. Additionally, the metabolic adaptation supported by “oncogenic mitochondria” is
a survival strategy developed in CRC cells. Unfortunately, the above metastatic cascade is formed and evolved
during the early tumor formation and progression stages. Activation of multiple tumorigenic pathways in CRC
cells leads to a poor five-year relative survival rate in patients with colon (14%) or rectal (17%) metastatic
cancer. Current natural anti-cancer compounds such as camptothecin and vinblastine have a successful
clinical profile. However, both camptothecin and vinblastine interfere with cell division, resulting in unwanted
effects on normal cells.
We have discovered that a natural plant-based anti-cancer molecule (veratridine [VTD]) induces the
expression of UBXN2A protein in CRC cells. UBXN2A’s ubiquitin-like activity suppresses the mTORC2-Rictor
pathway and mitochondrial mortalin, two critical tumorigenic players in CRC. This project aims to develop
“smart” nanoparticles (NPs) to selectively release VTD at tumor sites at high local concentrations while leaving
normal cells minimally exposed to the drug below its toxic concentrations. Our in vitro and animal experiments
have demonstrated the anti-growth and anti-metastatic effects of VTD at the cellular level and have aided in
elucidating its mechanisms. The proposed study will investigate the anti-growth and anti-metastatic
mechanisms of VTD delivered by casein-coated NPs in patient CRC-derived organoids (PDOs) (Aim 1). A
CRC metastatic mouse model with liver tumors will confirm the anti-metastatic mechanisms of NPs-VTD (Aim
2). Our central hypothesis is that casein-coated nanoparticles loaded with VTD (NPs-VTD) suppress the
overdriven mTORC2 pathway and interfere with the oncogenic mitochondria in CRC cells. Human tissues and
a human-like mouse model of metastatic CRC used in this study will open a platform for developing new
therapeutic strategies in CRC, particularly its metastatic forms.

Public health relevance
Public Health Relevance This study will develop a smart nanoparticle-based technology capable of unleashing the anti-cancer potential of veratridine, a plant-based molecule, at tumor sites. Understanding the fundamental mechanisms of veratridine will identify the contribution of tumorigenic pathways that selectively support tumor metastasis. This project can lead to the discovery of targeted therapies for primary and metastatic forms of CRC that is safer and more effective than current chemotherapies.